From Survival to Living Well: A Socioecological Approach to Understand Acquired Disability and Advance Health Equity in Rural Appalachia

ABSTRACT
People with disabilities are significantly more likely to experience chronic conditions and are at risk of dying up
to 20 years earlier than people without disabilities due largely to systemic and persistent health inequities.
Appalachian Kentucky, an underserved rural area, has twice the U.S. rate of disability—22.7% compared with
12.6% nationally. Rates of new or “acquired disability” are escalating as medical advances allow more people
to survive hospitalization and live with disability, yet we lack the knowledge to help people live well post-
hospitalization. Specifically, while formal medical care plays an invaluable role in saving the lives of people who
experience an acute health event, these survivors and their families are often left to manage the enduring
challenges of living with acquired disability on their own. I propose a mixed methods ethnographic investigation
to understand the nature of acquired disability, including subsequent care throughout the life course, in the
disproportionately affected rural communities of Appalachian Kentucky. Ethnographic studies enable a
holistic—personal, environmental, sociocultural, and political—perspective to understand individuals’ lived
experiences and identify opportunities to reduce adverse health outcomes. Long-term health is intimately
intertwined with broader cultural and structural factors that contribute to significant health disparities for rural,
disabled, and underserved populations, including informal (family and social relations), formal (health and
human services), and institutional (policy and programs) forms of care. Consistent with the socioecological
model, I will identify multilevel factors impacting quality of life and long-term health and identify strategies to
reduce health inequities. Obtaining grounded insights on how disability amplifies existing inequalities is
necessary to inform health, policy, and structural interventions to improve quality of life and long-term health for
people with disabilities. I propose two related aims: (1) to ethnographically investigate and describe
experiences of acquired disability among those with disabilities, family caregivers, health and human service
providers and policymakers and (2) to develop and verify a shared cultural model of disability describing the
range of barriers, facilitators, and opportunities to help rural Appalachians live well with disability. To achieve
these aims, I will obtain rigorous training in rapid ethnographic assessment, concept mapping, culturally
adapted interventions, and grant writing to support my growth as an independent health equity researcher. A
robust understanding of disability based on grounded experiences will inform future culturally adapted
interventions to mitigate health inequities and improve the lives of people with disabilities and their families.

Public health relevance
PROJECT NARRATIVE People living in rural and other underserved areas, such as Appalachia, are more likely to experience disability, morbidity, and premature mortality; despite the increasing prevalence of newly acquired disabilities and their negative impact on the well-being of rural residents, we currently lack grounded perspectives on barriers and facilitators to optimal quality of life and health outcomes for people with disabilities. Consistent with NIH’s recent recognition of people with disabilities as a “health disparity population,” the proposed research will investigate diverse factors and circumstances that contributing to health inequities for rural, disabled, and underserved populations. This mixed methods research will expand knowledge of disability in Appalachia; identify gaps in health and human services; illuminate strategies to address individual, interpersonal, and community, and policy-level challenges; and inform the future development and implementation of interventions across the socioecological model to improve the lives of people with disabilities and their families.